Dialysate regeneration system based on photo-electrochemical urea oxidation and reactive adsorption to enable portable hemodialysis

PROJECT SUMMARY/ ABSTRACT
Currently in the US there are over 400,000 kidney patients on dialysis. The primary therapy mode is
hemodialysis and is performed in a hospital or private clinic. Current dialysis therapy requires a large device
that must be continuously connected to a reverse osmosis (RO) system. A single treatment will require over
150L of AAMI dialysate making portable device unattainable. Kuleana Technology, Inc., in partnership with the
Center for Dialysis Innovation (CDI) and the University of Washington (UW), is developing a new technology
that will allow a hemodialysis therapy without the need for plumbing modifications to their home. The
equipment design target is to fit within the dimensions of standard rolling suitcases, enabling portability to
move between rooms, bring to the workplace or travel, which will expand the home hemodialysis (HDD) market
significantly. This technology, the Photo Oxidation Urea Removal, or POUR, system will remove uremic toxins
from the dialysis machine’s waste dialysate and recycle the clean dialysate back to the dialysis machine.
Allowing any dialysis machine to perform without a continuous water connection and only priming with a few
liters of sterile bagged water.
Kuleana Technology, incorporated in the State of Washington in 2020, is rethinking today’s hemodialysis. The
particular focus for Kuleana is portable, ambulatory dialysis (The AKTIV, ambulatory kidney to increase vitality)
and dialysis without a water hook-up or expensive and bulky urea sorbents. The CDI at UW focuses on
science advancements essential to portable hemodialysis. The CDI is funded by the Northwest Kidney Centers
(NKC), a not-for-profit dialysis provider seeking better care and outcomes for their patients. In a memorandum
of agreement between NKC and the University of Washington, a mechanism for IP flow between CDI, the UW
and Kuleana is specified (the UW, on behalf of CDI, has filed numerous patent applications). In addition, NKC,
has donated ample space and other resources to incubate Kuleana for the start-up effort. The space is within
one of NKC’s Seattle dialysis centers. The close proximity of medical personnel and patients will enhance HD
developments and save Kuleana considerable expense.
The CDI and the UW will be performing the necessary scientific research and development of the POUR
technology. The Hinds lab will build, test, and modify the initial POUR technology. Then, Kuleana Technology
will migrate these prototypes to the follow the necessary medical development processes and complete the
development of the POUR system into a Dialysis Regeneration Module which will be submitted to the FDA for
510k approval. All under the necessary QMS and DC as regulated by the FDA’s Code of Federal Regulation.

Public health relevance
PROJECT NARRATIVE In this project we are developing a novel technology that will allow a dialysis machine to operate untethered from a water source, based on a Photo Oxidation Urea Removal technology, called POUR. The Center for Dialysis Innovation at the University of Washington and Kuleana Technology, Inc. will develop portable dialysis devices in suitcase form factors with this POUR technology that will allow the patient to perform their treatment whenever and wherever they desire. With this new technology, patients can increase their weekly therapy to over 30 hours per week to more closely match continuous kidney function and improve patient outcomes that currently have only a 35% five year survival rate.